Career Development and Training Core

CAREER DEVELOPMENT AND TRAINING CORE
Modified Project Summary/Abstract Section
The NY-CHAMP Career Development and Training Core (CDTC) will serve as a local and regional scientific career development hub that 1) offers resources and activities to foster cross-disciplinary, cross-sector collaboration and 2) sets the stage for a highly interdisciplinary, highly collaborative network of scientists poised to advance innovative, community-centered, multi-level solutions for maternal health outcomes. The CDTC will draw on the rich institutional resources of Columbia and Cornell University Medical Centers and synergize with the vast knowledge and assets of our strong community, governmental, hospital, and academic partners to transform the pipeline of maternal health scientists to be interdisciplinary in approach and committed to community-centered, health outcomes focused research. In Aim 1, we will transform the maternal health research environment to create a pipeline of scholars who are committed to community engagement and expert in interdisciplinary, multi-sector research partnerships. In Aim 2, we will operate as a hub for maternal- health-focused training opportunities and resources. In Aim 3, we will engage early-stage investigator (ESI) NY-CHAMP Scholars in hands-on training in intervention science that is community-led, and interdisciplinary via a collaborative, to-be-designed demonstration project. Our training philosophy values co-creation and co- implementation of methods and interventions informed by, and responsive to the needs of the communities we serve. The CDTC will contribute to the overall goals of the NY-CHAMP Center of Excellence by grounding scholars and fostering innovative new science and sustained community partnerships for research impact on maternal health outcomes from the next generation of researchers.